Role of the Septin Cytoskeleton in Plasma Membrane Repair

Project Abstract
The plasma membrane (PM) forms a biophysical barrier that protects the cell from its extracellular environment
and regulates its functions. Mammalian cells are regularly exposed to stressors that can damage their PM.
Therefore, conserved molecular mechanisms repair the PM to maintain cell viability. Dysregulation of PM repair
mechanisms is involved in chronic or acute pathologies such as muscular dystrophy, ischemia-reperfusion, heart
failure, chronic inflammation, and neurodegenerative diseases. PM repair mechanisms can be exploited by
intracellular pathogens to successfully infect their host mammalian cells. The bacterial pathogen Listeria
monocytogenes produces the pore-forming toxin listeriolysin O (LLO) that perforates the cytoplasmic and
endocytic membranes to invade multiple cell types including epithelial cells, endothelial cells, cardiomyocytes,
macrophages, and neurons. The PM repair mechanism(s) of LLO-perforated cells are poorly understood. In a
preliminary screen, we identified the cytoskeletal protein, septin 7, as a protein required for the PM repair of cells
damaged by LLO. The septins are a family of highly conserved cytoskeletal proteins that act as scaffolds for
protein recruitment and vesicular trafficking. Septins are known to interact with the PM and the actin and
microtubule cytoskeletons to regulate numerous cellular functions. During PM repair of LLO-treated cells we
found that the septin filaments redistribute into subplasmalemmal loop structures that contain F-actin and
annexin A2 in a Ca2+-dependent manner. Until recently there was no known role of the septins in plasma
membrane repair. We plan to dissect the mechanisms used by the septins to repair the plasma membrane. We
will test the central hypothesis that septins play a general role in PM repair by controlling the
spatiotemporal organization of PM repair domains.
Using our expertise in quantitative fluorescence microscopy and the development of inducible cell lines, electron
microscopy, and proteomics, we will elucidate the role of septins in PM repair. We expect to determine how the
septins regulate PM repair and what molecules septin 7 interacts with during this mechanism. Together, these
studies will provide novel insights into septin biology and plasma membrane repair and provide new targets for
diseases involving plasma membrane repair.

Public health relevance
Project Narrative The plasma membrane is essential for normal cell functioning and cell homeostasis. During normal body functions (e.g., physical exercise and heart beating) as well as during disease states (e.g., bacterial infections, inflammation, cancer, and neurodegenerative diseases) the plasma membrane is constantly being damaged. Broadly we aim to find a novel role for the septin cytoskeleton in plasma membrane repair and open new research avenues in studying septins as targets for diseases in which membrane integrity is altered.